Feasibility and Acceptability of The Equus Effect: A Small Randomized Controlled Pilot Study of an Equine-facilitated Therapy

The VA Office of Patient Centered Care and Cultural Transformation's Whole Health initiative promotes the
use of complementary and integrative health (CIH) approaches with traditional medical care to help Veterans
achieve meaningful life goals and improved functioning. Equine-facilitated therapy (EFT), an animal-assisted
form of CIH, is increasingly available to Veterans within the VA. Horses have extreme sensitivity to the
emotional states, behaviors, and intentions of their herds and other animals, including humans, and mirror
body language and respond to subtle nonverbal cues. As such, horses have the capacity to provide immediate
feedback about a people's emotional and behavioral states. This capacity affords people opportunities to
become more emotionally self-aware and, with guidance from EFT facilitators, learn how to regulate emotions
and become calmer and more patient, attentive, and confident to gain the horses' cooperation. Participants in
EFT are encouraged to apply what they have learned from their equine experiences to their relationships with
people. Since high quality social functioning depends on effective regulation of one's emotions, EFT offers a
novel way in which to improve the social functioning of Veterans with mental health concerns. VAs are
increasingly embracing EFT as a CIH. However, carefully conducted, scientifically valid research about EFT
has not been conducted. Existing peer-reviewed research about EFT for mental health is very limited, of poor
methodological quality, and not focused on adults. None of it targets social functioning as a main outcome.
This small randomized controlled pilot test proposes to examine an innovative EFT called The Equus Effect
(TEE) as a complement to Veterans' existing VA mental health services to improve social functioning. TEE
aims to improve Veterans' social functioning by developing their emotion regulation and interpersonal skills
through therapeutic interactions with horses. This study will evaluate 1) the feasibility of study procedures,
assessments, and outcomes, 2) the fidelity of experimental and control interventions, and 3) the acceptability
of the interventions to Veterans and their mental health clinicians using mixed quantitative-qualitative methods.
The study has the potential to lend initial credibility to the therapeutic claims of this increasingly popular CIH.
Should data indicate that TEE and methods to study its effects are feasible and acceptable, it will set the stage
for a RR&D IIR proposal to test the efficacy of TEE in a multi-site randomized controlled trial.

Public health relevance
Equine-facilitated therapy holds promise as a complementary mental health intervention to improve Veterans' social functioning. We propose to test the feasibility and acceptability of a randomized controlled trial design to study an equine-facilitated therapy called The Equus Effect (TEE), which aims to improve emotion regulation and interpersonal functioning through interactions with horses. This 2-year small pilot trial will determine the feasibility of implementing TEE and study procedures and assessments and the acceptability of TEE to Veterans and their mental health clinicians.